Tribbles homolog 3 and BMP-2 induced bone formation

Project Summary
Osteoporosis affects craniofacial skeleton, jeopardizing dental procedures and healing processes.
Pathophysiologic processes of aging and osteoporosis are linked to the decreased osteogenic potential of bone
marrow mesenchymal stem cells (MSCs) and cell fate shift toward an adipogenic lineage. Although bone
morphogenetic protein-2 (BMP-2) is believed to be the most potent osteoinductive factor, efficacy and safety
concerns exist, including dose-dependent activation of peroxisome proliferator-activated receptor-γ (PPARγ) and
adipogenesis. Moreover, emerging evidence demonstrates aberrant BMP signaling in osteoporotic patients and
impaired osteogenic response to BMP stimulation. During the initial funding period, we discovered the reciprocal
role of tribbles homolog 3 (Trb3) in the regulation of osteogenic and adipogenic differentiation of MSCs.
Importantly, Trb3 enhanced bone regenerative capacity and quality of BMP-2 by inhibiting PPARγ activity and
fatty tissue formation. Our preliminary study showed that systemic administration of Trb3 reversed ovariectomy
(OVX)-induced osteoporotic phenotype in mice. This renewal aims to further investigate whether Trb3 can
promote osteogenesis in a more challenging, systemic bone disease and enhance effectiveness of BMP-2 in the
treatment of osteoporotic bone defects. In addition, current systemic therapy is hampered by off-target effects
and insufficient efficacy. Thus, this study will further enhance the efficacy and safety of Trb3 delivery by
employing our newly developed targeted nanocarriers. The specific hypothesis is that delivery of Trb3 gene via
viral vectors or bone targeting exosome mimetics (EMs) will regulate MSC adipo-osteogenic differentiation in
osteoporosis, reverse osteoporotic bone loss, and promote bone regeneration efficacy of BMP-2 in osteoporotic
bone defects. Three specific aims are proposed to investigate this hypothesis. In Aim 1, we will evaluate the
ability of Trb3 to protect against bone loss in OVX or aging rats by injecting viral vector encoding Trb3 into rats.
We will also investigate regulatory mechanisms of Trb3 action in preventing osteoporosis using MSCs isolated
from OVX or aged rats treated with Trb3. Next in Aim 2, we will evaluate the ability of Trb3 to promote bone
healing in OVX rats with peri-implant bone defects. We will also apply BMP-2 in the defects and investigate
whether Trb3 treatment can enhance BMP-2 osteogenic effects while reducing defect site adipogenesis. Finally
in Aim 3, our recently developed EMs will be applied to deliver Trb3. We will introduce apatite and MSC binding
moieties into the EM surface and investigate whether the targeted EMs can be accumulated in bone tissues with
low systemic toxicity. Effects of systemic administration of Trb3-loaded EMs on alleviating bone loss will be
evaluated in OVX rats. Successful completion of the proposed studies will identify a new strategy that could
better regulate adipo-osteogesis of MSCs and bone formation in osteoporosis, and could improve effectiveness
of BMPs in the treatment of osteoporotic bone defects.

Public health relevance
Relevance to Public Health Osteoporosis is one of major public health concerns for aging adults, leading to bone fragility and increased risk of fractures. The proposed research provides the foundation for developing a new therapy for prevention and treatment of osteoporosis and fracture. Results from these studies will improve health for millions of people with disorders of bone metabolism.